Role of Complement Activation in Severe COVID-19

PROJECT ABSTRACT
We recently developed sub-lethal lethal mouse model of Covid-19 (K18-hACE2). We infected
these mice with influenza virus or sublethal SARS-CoV-2 infected K18-hACE2 mice to study
pathobiology of Covid-mild 19 disease and to identify treatment modalities for long Covid. These
studies revealed that both influenza and sub-lethal dose of SARS-CoV-2 causes transients weight
loss and damage lung epithelial cells as expected. However, influenza induced inflammation was
resolved by proliferation of basal lung epithelial cells organized into pod structure and lung
regeneration while sub-lethal SARS-CoV-2 induced inflammation resulted in lung fibrosis. At the
molecular level influenza infection induced expression of Keratin genes (Krt5, 15, 16) at
dramatically higher levels compared to sub-lethal dose of SARS-CoV-2, consistent with tissue
repair in lungs of influenza but fibrosis in the lungs of sub-lethal SARS-CoV-2 infected mice.
Importantly, influenza induced much stronger interferon response while SARS-CoV-2 induced
much stronger cytokine response, complement response, and fibrosis. These data indicate that
a more robust innate immune response, attenuated cytokine and complement response, and
activation of pro-resolving molecules may help reduce the mortality and morbidity of SARS-CoV-
2. Omega 3 polyunsaturated fatty acids (n-3 PUFAs) fulfil these criteria because they activate
direct anti-viral response proteins and are the precursors of the pro-resolving lipid mediators that
favor tissue repair. Indeed, n-3 PUFAs reduce lung fibrosis induced by various chemical and
environmental assaults.
In this supplemental proposal we will feed sub-lethal SARS-CoV-2 infected mice with n-3
PUFA or n-6 PUFA (control) supplemented diets to test the hypothesis that n-3 PUFAs will
improve innate immune response to SARS-CoV-2 infection by moderating the initial injury as
determined by weight loss and initial lung injury. We hypothesis further that by increasing tissue
and blood concentration of pro-resolving lipid mediators, n-3 PUFAs will promote tissue repair
over fibrosis in mice infected with sub-lethal dose of SARS-CoV-2. If these studies are successful
they will open a path for human clinical studies aimed at using n-3 PUFAs as nutritional
substances to reduce morbidity of long Covid, either alone or in combination with other agents
such as complement inhibitors.

Public health relevance
PROJECT NARRATIVE This supplement application will utilize our newly developed state-of-the-art tools to investigate supplementation of diets with long chain omega 3 (n-3) polyunsaturated fatty acids (PUFAs) for reducing the morbidity and/or mortality of COVID19 by reducing exaggerated inflammatory response including complement activation. The significance of our proposed research lies in the fact that it will help us better understand the role of C activation and the MAC in pathogenesis of COVID-19, provide a new tool that modulate activity of C system for reducing morbidity and mortality COVID-19, thus fostering the development of additional therapeutic strategies encompassing the C system.